Deciphering the role of CD44 astrocytes in Alzheimer's disease

Alzheimer's disease (AD) is the most prevalent neurodegenerative disorder, characterized by
neurofibrillary tangles, β-amyloid (Aβ) plaques, and astrocyte dysfunction. Astrocytes play critical roles
in AD pathophysiology, including Aβ clearance and modulation of neuroinflammation. Thus, astrocytes
are essential in the pathogenesis of AD, yet the molecular mechanisms underlying astrocyte pathology
in AD are not fully understood. Robust evidence from the literature and our preliminary data in human
AD tissue and an AD mouse model shows an increase in a population of astrocytes characterized by
expression of the matrix-protein receptor CD44. However, the precise contributions of CD44 astrocytes
to AD pathology are unknown. Our detailed initial investigations revealed an elevated spatial
correlation between CD44 expression and Aβ plaques in both human AD patients and a murine AD
model - suggesting a potential role for CD44 in disease initiation or progression. This proposal builds
on this foundation and aims to comprehensively define the functional role of CD44 in AD disease-
associated astrocyte states. Overarching hypothesis: CD44 upregulation in astrocytes drives a
specific disease-associated astrocytes state and promotes AD pathology. Aim 1 will elucidate the
signaling mechanisms by which CD44 alters astrocyte phenotype and function in vitro. This will involve
genetic and pharmacological manipulation of CD44 cleavage and CD44 intracellular domain (ICD)
signaling pathways, evaluating downstream effects on astrocyte biology, including morphology, gene
expression, and functional responses. Aim 2 will investigate the impact of astrocytic CD44 on neuronal
dysfunction using AD cellular models. Co-culture experiments with cortical murine and induced
pluripotent stem cell (iPSC)-derived neuronal AD models will assess how astrocyte CD44 perturbations
affect neuronal viability, synaptic function, and transcriptomic profiles. Leveraging single-nucleus RNA
sequencing (snRNAseq), this aim will correlate in vitro findings with changes observed in AD patient
brains to validate the relevance of CD44-dependent mechanisms in disease pathogenesis. Aim 3 will
explore the in vivo effects of modifying CD44 in an AD mouse model, utilizing a novel astrocyte-specific
Cd44 knockout mouse and targeted viral expression strategies. We will employ multiplex
immunofluorescence, snRNAseq, spatial transcriptomics, and behavioral assays to quantify changes in
astrocyte states, Aβ pathology, and cognitive decline. By targeting CD44 at early and late stages of
pathology, this aim will determine how manipulating CD44 can mitigate or exacerbate
neurodegenerative outcomes. Impact: This study will advance our understanding of CD44-mediated
mechanisms in AD, proposing CD44 as a potential therapeutic target for modulating astrocyte-driven
neurodegeneration and improving outcomes in AD patients.

Public health relevance
Alzheimer's disease is an incurable, lethal, neurodegenerative disease driven by pathologies in multiple cell types, including astrocytes. Astrocytes, the guardians of the brain microenvironment, become dysfunctional in Alzheimer's disease, and we have identified a disease-associated astrocyte state characterized by elevated expression of the matrix-protein receptor CD44. Here, we will define the role of CD44-astrocytes in Alzheimer's disease utilizing in vitro and in vivo models with experiments designed to elucidate how CD44 regulates astrocyte phenotypes and function, impacts neuronal dysfunction, and influences disease progression – which will potentially uncover novel therapeutic targets.